The Indiana Training Program in Public & Population Health Informatics

Project Summary / Abstract
The Indiana Training Program in Public & Population Health (PPH) Informatics trains the next generation of
pioneering PPH informatics researchers, faculty, and leaders, prepared to advance the state of knowledge in the
field and conduct research over the course of their careers that uses biomedical informatics and data science to
advance the health of the U.S. population. Over the past five years, our program has trained 12 PPH informatics
researchers who are helping modernize the nation’s public health infrastructure and strengthen approaches to
managing and analyzing population health data. Building on these and other successes, including the
establishment of a vibrant and flourishing educational, institutional, and technical infrastructure to support these
trainees, we are now positioned to grow our program and its value as outlined in this application for competitive
renewal. The program continues to have two overarching goals: 1) train predoctoral and postdoctoral scientists
for successful careers in PPH informatics research; and 2) recruit and graduate high-caliber trainees with diverse
backgrounds, races/ethnicities, and research disciplines. Our program equips trainees with advanced data and
information science skills to address biomedical informatics research challenges in the context of public and
population health. Predoctoral trainees pursue a PhD in epidemiology, health policy and management, or
biostatistics with a doctoral minor in population health analytics. Postdoctoral trainees obtain further training that
includes a research-oriented master’s degree if they lack prior training in PPH informatics. The educational
program for all trainees consists of coursework; a substantial research project culminating in dissertation for PhD
students and thesis for master's students; purposeful mentorship and guidance in meeting training goals; and
associated publications, presentations, and other academic activities related to their research with expert faculty
mentors. In this next funding cycle, we propose to train a steady state of 9 predoctoral trainees and 5 postdoctoral
trainees, including two trainees focused on HIV research. Overall, we aim to build on our past successes by: 1)
expanding the number of trainees served by our program; 2) expanding coursework and research experiences
in the area of clinical informatics, including a focus on training HIV researchers who can apply PPH informatics
methods to enhance surveillance and care for people living with HIV; 3) improving coursework in the areas of
data science and analytics; and 4) expanding and achieving greater diversity among our faculty and trainees.

Public health relevance
Project Narrative To advance public and population health (PPH) within the U.S. healthcare system, we seek to continue training researchers in PPH informatics through an institutional educational program offered by the Regenstrief Institute, Indiana University (IU) Fairbanks School of Public Health, and IU School of Medicine. The program leverages our institutions’ unparalleled population-level data and information systems, close working relationships with multiple innovative health systems, and advanced data science approaches to train the next generation of pioneering PPH informatics researchers, faculty, and leaders.